Microglia contribution to disease pathogenesis in C9orf72 ALS/FTD

Project Abstract
The role of microglia in the C9orf72 (C9) amyotrophic lateral sclerosis (ALS)/ frontotemporal dementia (FTD)
disease spectrum remains poorly understood. Early investigations found that microglia activation was
significantly higher in ALS with dementia and impaired executive function, suggesting that microglia activation
correlates with FTD-like symptoms in ALS. More recent neuropathologic examinations of microglia in FTLD
patient autopsy brains with mutations in progranulin versus C9orf72 concluded that the observed microglia
dysfunction was different between the two genetically different patient subgroups suggesting specificity of
microglia dysfunction depending on the etiology of the patient population. One interesting aspect of microglia-
neuron communication is the role of microglia in the maintenance and refinement of synaptic networks through
the selective pruning of synapses, which occurs predominantly during development but has been shown to also
be triggered in Alzheimer's disease (AD) and related dementias, including FTD. The degree of synapse loss in
AD strongly correlates with cognitive decline, even more than the amount of plaque, tangles or neuronal loss,
and a recent study of ALS postmortem tissue confirmed increased synapse loss in the prefrontal cortex of
patients with reported cognitive impairments. Our laboratory has preliminary data supporting the hypothesis that
there is an altered neural-immune interaction in the cortical forebrain regions of C9orf72 patients with
confirmed FTD in which microglia and neurons modify each other's function. Using patient-derived hiPSC
microglia and cortical neurons, we are able to show that C9 patient-derived hiPSC microglia mono-cultures do
have intrinsic phenotypes, including altered gene profiles, phagocytic activities and lysosomal function. Most
interestingly, preliminary data suggests that C9 microglia do regulate neuronal excitability and survival of C9
iPSC neurons. To further investigate the role and contribution of microglia in C9 cortical degeneration, we
propose to thoroughly investigate the intrinsic properties of C9 hiPSC-microglia (from all patient subgroups: FTD,
FTD/ALS, ALS; Aim1). For the first time, we will then co-culture these microglia with C9 and healthy control
hiPSC cortical neurons to better understand the co-regulation between these two cell types (Aim 2). Finally, in
the third aim, we will study microglia activation and pathology in C9 patient postmortem autopsy tissue. This will
include cell-type specific genetic profiling from existing snRNA seq data sets, immunohistochemistry of
microgliosis and multi-label immunostaining for microglial-specific candidate genes/proteins in conjunction with
C9 neuronal disease pathology markers (TDP-43 and C9 DPRs) to gain novel knowledge on whether microglia
are preferentially altered in close vicinity to neuronal pathologies.

Public health relevance
Project Narrative The proposed studies will provide novel information on the role of microglia in disease mechanisms and neuronal dysfunction in C9orf72 patients clinically diagnosed with frontotemporal dementia (FTD). While microglia activation is known to occur in this patient population through postmortem autopsy studies, a much better understanding is needed regarding the extend of microglia-neuron co-regulation and the existence or absence of non-cell autonomous disease mechanisms similar to what has been described for astrocyte and motor neurons in other neurodegenerative diseases, including amyotrophic lateral sclerosis (ALS). The proposed studies will provide novel opportunities for drug target identification and future drug discovery efforts with the hope of identifying novel therapeutics for these affected patient populations.